Alliance NCORP Research Base

Alliance NCORP Research Base
Project Summary/Abstract
The Alliance for Clinical Trials in Oncology (Alliance), one of five National Clinical Trials Network groups,
serves as the parent organization for the Alliance NCI Community Oncology Research Program (NCORP)
Research Base (Alliance NCORP). The Alliance NCORP conducts interventional and observational clinical
and translational research as well as database studies – all of which address important questions relevant to
cancer prevention, symptom control, and cancer care delivery. In addition, the Alliance NCORP conducts
clinically important quality of life studies that are embedded within cancer treatment trials. It places special
emphasis on minority, underserved and older patients at risk for or diagnosed with cancer, and on building
strong collegial relationships with NCORP Community sites and Minority/Underserved Community sites. The
Alliance NCORP committee membership includes rich representation from both community-based and
academic medical centers, as well as patient advocates, thus generating research results relevant to cancer
patients across the United States. The Alliance NCORP also emphasizes mentorship and training of junior
investigators. Over this past grant cycle, i.e., since August 2014, the Alliance NCORP has published 148
manuscripts and abstracts. This work has included practice-changing research in such areas as the
prevention of chemotherapy-induced nausea and vomiting, the prevention of skeletal-related events from
osseous metastases, the management of brain metastases, and the integration of patient-reported outcomes
into cancer clinical trials. The Alliance NCORP conducts translational research that requires the collection of
tumor tissue, premalignant tissue samples, blood, and other human biospecimens; and shares data and
biospecimens for pooled analyses and other scientific collaborations. These biospecimens create an
invaluable repository for understanding clinical observations from a mechanistic standpoint. The Alliance
NCORP also collaborates broadly with other NCI-funded investigators and consortia, as well as with
investigators supported through non-NCI sources. This practice-changing research and the scientific
questions answered by the Alliance NCORP provide meaningful and innovative contributions to clinical and
translational oncology, which can be conducted only within a publicly-funded research network.

Public health relevance
Alliance NCORP Research Base Project Narrative The Alliance NCI Community Oncology Research Program (NCORP) Research Base conducts research in cancer prevention, cancer symptom control, and cancer care delivery with a special emphasis on minority, underserved, and older patients and with a strong commitment to building collegial relationships with NCORP Community sites and Minority/Underserved Community sites. The Alliance NCORP seeks to continue its mission into the next grant cycle of generating practice-changing research that directly and favorably impacts the lives of cancer patients and those at risk for cancer.